Novel Reengineered Microbiome-based Biologic Therapy to Treat Cognitive and Behavioral Symptoms of Alzheimer's Disease and Related Dementias

Abstract
Our early-stage ADDP proposal aims to develop a novel genetically engineered bacterial biologic to treat the
most common early symptoms of Alzheimer's disease (AD), including cognitive impairment and other
neuropsychological symptoms, such as anxiety and depression. This debilitating disease imposes a huge
emotional, social and financial burden on society. No effective disease-modifying AD drug exists to dampen the
Aβ and tau proteinopathies associated with disease progression. Current FDA-approved cholinergic and
glutamatergic neurotherapeutics are very modest at best in rescuing memory in mild cognitive impairment (MCI)
and prodromal or early stages of AD cases, and often worsen anxiety, apathy, depression, agitation, and other
neurobehavioral symptoms, GI irritations, and even mortality. Recent biological evidence indicates that AD is a
neural circuit disorder. The onset and progression of cognitive and behavioral symptoms involve a deficiency in
monoamine neurotransmitter signaling networks, including norepinephrine (NE) and dopamine (DA). Thus, we
propose that restoring brain DA/NE inputs holds the excellent potential to be an effective approach to alleviating
cognitive and behavioral deficits in AD and could even delay disease onset. Currently, oral tablet dosing of L-
DOPA/carbidopa 3-4 times/day remains the most effective therapy at restoring brain DA/NE levels in humans.
However, this repeated chronic pulsatile delivery causes severe side effects. Thus, our therapeutic hypothesis
to address this unmet clinical problem is that systemic delivery of genetically engineered L-DOPA bacterial live-
therapeutics (LDBL) will avoid large fluctuations in plasma L-DOPA and provide more consistent delivery of L-
DOPA to the brain for restoring DA/NE to stable levels that better relieve AD symptoms without additional side
effects. Our proof-of-concept data support that 1) the genetically engineered probiotic E. coli Nissle 1917 strains
(EcNL-DOPA) efficiently produce L-DOPA both in vitro and in vivo, 2) oral dosing of EcNL-DOPA readily colonizes the
mouse gut, achieves a steady-state plasma L-DOPA level that corresponds to the clinically effective plasma
level in humans, and increases L-DOPA and DA/NE levels in the brain of rodents and canines, and 3) EcNL-DOPA
treatment leads to improved neurobehavioral outcomes and reduces Aβ levels in AD animal models including
canines. The overarching goal of our patent-pending ADDP strategy is to optimize the lead LDBL and test
its preclinical efficacy in alleviating the cognitive and behavioral deficits, such as apathy, of early AD.
To achieve this goal, we will pursue the following specific aims: (i) Optimize the lead LDBL for animal testing, (ii)
Evaluate the chronic pharmacokinetic (PK), and safety profile of the lead LDBLs for preclinical efficacy studies,
(iii) Determine in vivo pharmacodynamic (PD) efficacy of two lead LDBLs in transgenic (Tg) AD rodent models,
and (iv) Assess the efficacy of the most effective lead LDBL in canine models of dementia. Together, our unique
therapeutic pipeline strategy involving chronic delivery of probiotic L-DOPA is expected to establish a new line
of engineered microbiome-based monoamine neurotherapeutic modalities for AD-related dementias (ADRD).

Public health relevance
Narrative: Signaling networks deficient in monoamine neurotransmitters have been linked to the onset and progression of intellectual deficits in Alzheimer's disease (AD). Thus restoring norepinephrine and dopamine inputs represents an effective approach to alleviating AD's cognitive and behavioral symptoms and could delay disease onset. Dopamine replacement therapy with the dopamine precursor L-DOPA remains the most effective treatment for restoring DA/NE inputs in humans. However, the L-DOPA oral tablet's pulsatile delivery is often associated with severe adverse effects after long-term use. Thus, the main goal of this proposal is to develop and optimize a novel therapeutic platform of live biological L-DOPA delivery to restore monoamine neurotransmitters to steady-state levels that relieve symptoms of ADRD without adverse effects.